The Health Consequences of Childhood Maltreatment and Foster Care From Adolescence Into Mid-Life

PROJECT SUMMARY
Child abuse and neglect are common among US children and consequential for later-life
health and wellbeing, including hypertension, obesity, cardiovascular functioning, substance
use, and depression. Foster care placement, which is an important strategy through which
Child Protective Services (CPS) remedy the risk of future harm, is also associated with
myriad deleterious outcomes. Because each of these experiences—child maltreatment and
foster care placement—are unevenly distributed by race and socio-economic status, they
may contribute to health inequalities. Unfortunately, prior research on the effects of both of
these childhood experiences is generally limited to the study of health in adolescence or
early adulthood and does not differentiate health consequences due to maltreatment from
health consequences due to foster care placement. Indeed, few studies consider the
potentially moderating effects of maltreatment dosage on health outcomes or control for
well-established determinants of health, such as genetic disposition, personal behavior, and
environmental contexts. These limitations significantly diminish knowledge about the
potentially heterogeneous effects of childhood traumatic events on health and wellbeing, the
persistence of those effects throughout the life-course, and the potentially remedial or
additive effects of important state interventions in family life. This in turn constricts the ability
to design policies that reduce long-term health disadvantages among vulnerable children
without introducing new sources of social vulnerability. Our project closes this knowledge
gap by leveraging the unique advantages of the National Longitudinal Study of Adolescent
to Adult Health (Add Health), which tracks a national cohort from childhood into mid-life and
includes detailed measures of childhood victimization as well as unique biomarker data and
information on core social determinants of health. The project uses these data to (1) extend
the scope of existing associational studies of health outcomes from early adulthood until
mid-life, (2) study the persistence of health disadvantages among maltreated and fostered
children, (3) disaggregate the effects of maltreatment and foster care on health outcomes,
and (4) assess how such effects differ across socio-demographic categories and the dosage
of childhood abuse and neglect.

Public health relevance
PROJECT NARRATIVE This study will advance knowledge about the consequences of childhood maltreatment and foster care placement for adult health and wellbeing. We use data from the National Longitudinal Study of Adolescent to Adult Health (Add Health), which includes detailed measures of childhood victimization as well as unique biomarker data and information on core social determinants of health. The project uses these data to (1) extend the scope of existing associational studies of health outcomes from early adulthood until mid-life, (2) study the persistence of health disadvantages among maltreated and fostered children, (3) disaggregate the effects of maltreatment and foster care on health outcomes, and (4) assess how such effects differ across socio-demographic categories and the dosage of childhood abuse and neglect.